NEI Center Core Grant for Vision Research

SUMMARY
Overall
The overall purpose of the Vision Research Core Grant is to provide core services and resources to
enhance and accelerate the productivity and impact of the vision research community at University of
California, San Diego. Specifically, the Vision Research Core grant will leverage the outstanding basic
science and clinical research expertise of National Eye Institute funded investigators by providing important
resources and services organized into the following 4 distinct cores.
1. The Biostatistics Core will provide dedicated statistical expertise for the vision research community at
UCSD. There are several common analysis themes and statistical issues that can be addressed effectively
and efficiently by having a dedicated biostatistician familiar with eye research to analyze vision related data
and to ensure rigor and transparency of the results.
2. The Animal Structure and Function Core will provide shared instrumentation and a technician to assist
with ocular structural imaging and functional imaging in animals.
3. The Computational Ophthalmology core provides i) dedicated high-performance CPU and GPU
computing resources ii) a computer programmer, iii) institutional software licenses and iv) secure file
sharing and backup services to support UCSD's cellular, animal and human vision research studies.
4. The Tissue Processing and Histology Core provides rapid characterization of eye tissue with respect to
histology, immunohistochemistry and confocal microscopy by supporting instrumentation and a technician
who is familiar with ocular anatomy and techniques required to properly process ocular tissues.
These cores will improve the efficiency and productivity and impact of UCSD vision scientists by providing
core services that are unavailable to individual investigators. The core grant infrastructure and resources
also leverages the expertise of each participating investigator to enhance multidisciplinary collaboration for
the benefit of the entire UCSD vision research community.

Public health relevance
NARRATIVE Overall The UCSD Vision Research Core Grant will provide core services and resources to enhance and accelerate the productivity and impact of vision research at UCSD. These resources will be used to foster collaboration among faculty from the Departments of Ophthalmology, Pathology, Pediatrics, Institute for Genomic Medicine, Neurosciences, Pathology, Pharmacology and Psychology to bring us closer to our goal of the prevention and cure of blinding eye diseases such as glaucoma, macular degeneration and diabetic retinopathy.